Helping Everyone Achieve a LifeTime of Health - Future Addiction Scientist Training

PROJECT SUMMARY/ABSTRACT
The HEALTH Research Institute was established at UH to pursue a bold research agenda aimed at addressing
the public health crises health disparities inflict on our most vulnerable communities. Investing in a new NIDA
R25 at UH represents an excellent strategic investment in establishing a diverse pipeline of future substance
abuse scientists given our: (1) central location in arguably the most ethnically diverse metropolitan area
(~44% Latinx, ~26% White, ~23% Black, and ~7% Asian) in the U.S.; (2) one of the only Tier-1 research
institutions with a Hispanic-Serving Institution (HSI) and Asian American and Native American
Pacific Islander-Serving Institution (AANAPISI) designation; (3) ~400 health research faculty and
97 degree programs who will benefit from a research education program that focuses on substance abuse
given Houston’s designation as a high-intensity drug trafficking area (HTDTA); and (4) the institutional
investment in the HEALTH Research Institute which will house this proposed NIDA R25 to ensure it addresses
substance abuse education and research training across the University and beyond. This HEALTH – Future
Addiction Scientist Training (HEALTH-FAST) Program will focus on annually enrolling and advancing the
careers of Doctoral (n=4), Postdoctoral (n=2), and Early Stage Investigators (ESI) Trainees (n=2) – with a
total of 40 Trainees from underrepresented backgrounds in the health sciences across the 5-year funding
period. This will be achieved by the successful completion of 4 specific aims: (1) Identify, select, educate, and
mentor highly qualified Doctoral, Postdoctoral, and ESI Trainees from underrepresented groups in the health
sciences for substance abuse research careers with an emphasis on linkages to ATOD-related chronic diseases
and health disparities; (2) Develop a cutting-edge substance abuse research education curriculum that will
include an array of diverse activities that are reflective of emerging national trends to facilitate an enriching
educational experience; (3) Advance skills needed to effectively disseminate innovative scientific research at
professional meetings and in peer-reviewed journals, while simultaneously accelerating Trainees’
competitiveness to secure NIDA grant funding; and (4) Systematically evaluate HEALTH-FAST processes,
programming, and Trainee outcome data in real-time to demonstrate a NIDA return on investment and inform
data-driven program modifications as needed. Given the proposed transdisciplinary approach to health-equity
science, the HEALTH-FAST Program will leverage Program Faculty Mentors across 7 colleges and 12 academic
units (i.e., Biomedical Engineering; Biomedical Sciences; Clinical Sciences; Electrical & Computer Engineering;
Health & Human Performance; Health Systems & Population Health Sciences; Medicinal Chemistry;
Pharmaceutical Health Outcomes and Policy; Psychological, Health, & Learning Sciences; Psychology; Biology
& Biochemistry; and Social Work) to execute a cutting-edge research education program.

Public health relevance
PROJECT NARRATIVE The diversity, population size, and health challenges of metropolitan Houston provides an ideal setting for a new NIDA R25: Providing Research Education Experiences to Enhance Diversity in the Next Generation of Substance Abuse and Addiction Scientists. The University of Houston (UH) will leverage its Helping Everyone Achieve a LifeTime of Health (HEALTH) Research Institute and NIMHD RCMI (HEALTH Center for Addictions Research and Cancer Prevention) to serve as the platform for executing an innovative substance abuse research education program to the future generation of scientists underrepresented in the biomedical, behavioral, clinical, and social sciences. The HEALTH – Future Addiction Scientist Training (HEALTH – FAST) Program will leverage a transdisciplinary approach to health-equity science with a focus on how substance use/abuse leads to chronic diseases that disproportionately affect health-disparity populations.